Development of a multiplexed assay in kinetoplastid parasites to identify probes for glycolysis

Project Summary/Abstract
This Diversity Supplement to the award R01AI156382, "Development of a multiplexed assay in kinetoplastid
parasites to identify probes for glycolysis” will support the training of Sabrina Pizarro, a Clemson University
graduate student in the Department of Genetics and Biochemistry that is from the Catawba Indian Nation, an
under-represented group in the sciences. The goal of this project is two-fold. First, the project will support
Sabrina’s research effort to develop and validate new molecular tools for use in the African trypanosome,
Trypanosoma brucei. Sabrina will generate procyclic form (PF) and bloodstream form (BF) T. brucei parasites that
express a protein pH biosensor based on pHluorin2. pHluorin2 is a ratiometric pHluorin variant that displays a pH
(acid) dependent excitation that can be readily monitored by flow cytometry and microscopy. PF and BF parasites
expressing these sensors will be used to resolve cellular mechanisms of acidification or the subcellular organelle
that houses glycolysis, the glycosome. The pH sensing cell lines will serve an additional purpose, playing a role in
the work described in the parent proposal. The pHluorin2 lines will be used as a counterscreen, allowing us to
discriminate small molecules that influence glycolytic enzyme activity by disrupting cellular or glycosomal pH from
those inhibitors that more directly inhibit enzymes in the pathway. The second goal of the project is to support
Sabrina’s professional development as she works to achieve her career goals. Through interactions with the PI
and co-mentor, along with participation in a variety of professional development opportunities, we anticipate that
Sabrina will be fully positioned to successfully pursue the next step in her career path.

Public health relevance
PROJECT NARRATIVE In this Research Supplement to Promote Diversity in Health-Related Research to the award R01AI156382, "Development of a multiplexed assay in kinetoplastid parasites to identify probes for glycolysis”, Sabrina Pizarro will develop, validate, and interrogate a parasite cell line that express a pH biosensor. In the parent award, we are working toward identify small molecule probes capable of inhibiting glucose uptake and metabolism in kinetoplastid parasites, and it is known that regulable acidification of cellular compartments that house glycolysis inactivates the pathway. Therefore, Sabrina’s efforts will enable us to identify those small molecule inhibitors in our screen that are identified in our screen as a consequence of altering cellular pH.